Increasing Availability of Emulsion Adjuvants via Synthetic Biology

Squalene-based oil-in-water emulsions, such as MF59, have been shown to demonstrate adjuvant activity in a variety of vaccine settings, including seasonal influenza vaccine. The awardee seeks to develop a mimic of MF59 using squalene that has been sustainably synthesized by yeast cultures. This adjuvant will be tested in preclinical studies and advanced toward large production capacity.